Accelerated Sarcopenia in Early Alzheimer's Disease

Summary:
Accumulating evidence indicates that AD patient physical function gradually declines long before cognitive
symptoms warrant a clinical diagnosis of dementia. These early changes often develop in regions that promote
and coordinate motor function. Located throughout the central nervous system, they extend via peripheral
nerve pathways into musculoskeletal structures. Elucidating these motor mechanism(s) may point toward
effective AD interventions.
In AD, loss of lean muscle mass precedes brain atrophy and cognitive impairment by several years. AD
patients show reduced physical activity, suggesting that associated behavioral changes may result in loss of
lean mass. However, even after controlling for physical activity levels, lean mass is independently associated
with brain volume, so the decline in physical activity observed in AD does not fully explain accelerated loss in
muscle mass and strength (sarcopenia) in early AD. We propose that damage to brainstem sympathetic
neurons (SNs), which regulates cognitive and skeletal muscle function, leads first to sarcopenia, then cognitive
impairment.
We propose that a subgroup of pontine noradrenergic neurons (A5) that project to spinal cord intermediolateral
column (IML) preganglionic and, through them, to postganglionic SN and hindlimb muscles (Sympathetic
Neurons Projecting to Hindlimb Muscles, SNPHLM), regulates motoneuron function, neuromuscular junction
(NMJ) transmission, and skeletal muscle innervation, mass, and strength. The remaining A5 neurons synapse
with several targets, including the locus coeruleus (LC) neurons (A6), which are essential to maintaining
cognitive function,but not with the NMJ. With AD, A5 SNPHLM become susceptible to cumulative damage,
which accounts for early motor deficits. Optogenetics, chemogenetics, and viral vector retrograde neuron
labeling provide new opportunities to define the role of A5 SNPHLM in AD muscle pathology and function.
The aims of this project are: (1) To define the role of A5 SNPHLM in muscle motor denervation, impaired NMJ
transmission, decreased norepinephrine (NE) release at the NMJ, and diminished adrenoceptor GPCR-
mediated signaling in the early, middle, and late stages of AD; and (2) To determine whether chemogenetic
modulation of A5 SNPHLM at various stages of AD enhances skeletal muscle sympathetic and motor
innervation and delays or reverses accelerated sarcopenia.
This project will define the role of central autonomic neurons in AD sarcopenia and predict disease
progression. Analysis of autonomic central regulators of skeletal muscle structure and function will enable
detection of predementia AD and formulation of effective treatments for each disease stage.

Public health relevance
NARRATIVE This project will define whether central autonomic neurons regulate neuromuscular junction transmission and skeletal muscle structure and function, and their vulnerability to cumulative damage over time accelerates sarcopenia and motor deficits in early Alzheimer’s Disease (AD). This study will define the mechanisms by which impaired central autonomic network regulation of the peripheral SNS leads to skeletal muscle sympathetic and motor denervation, and loss in mass and strength, and will enable detection of predementia AD and formulation of effective treatments for each disease stage.